Academic Centers of Excellence in Youth Violence Prevention

Academic Centers for Excellence: Denver Collaborative to Reduce Youth Violence Project Summary/Abstract Youth violence prevention efforts have primarily focused on single stream methods to address youth violence. This approach has yielded a number of evidence-based (EB) programs and strategies that target youth problem behaviors, implemented in a variety of settings (i.e., school, social services), with varying target populations and age groups. More limited research has examined the effects of combining single stream efforts into multi-faceted (MF) approaches to effect more pervasive community-wide outcomes. The Center for the Study and Prevention of Violence proposes to develop an Academic Center of Excellence (ACE) in Denver to initiate a MF-EB approach to addressing youth violence. The proposed study will enhance the body of research associated with studies on community-wide prevention efforts and will advance our understanding of what works at this level of implementation. Immediate and long-term goals are to 1) reduce levels of violence among those aged 10-24 in the Montbello neighborhood, compared to the Northeast Park Hill (NEPH) neighborhood, 2) implement and evaluate a MF- EB primary prevention/intervention approach, 3) provide training for junior youth violence prevention researchers in behavioral science, public health, and adolescent medicine, 4) provide training to medical practitioners to recognize and treat youth violence, and 5) embed activities coordinated through the ACE into the existing community infrastructure of youth services to ensure sustainability after completion of the grant. The sites participating in this study are two of Denver's most high- risk residential neighborhoods. Public Safety data (2009) show that in Montbello, the overall crime rate per 1,000 people was 53.3 and the associated violent crime rate was 11.3. In NEPH, the overall crime rate per 1,000 people was 71.1 and the associated violent crime rate was 13.5. Data on hospitalizations for assault among ages 10-24 show that both communities reported an average of 10.9 hospitalizations a year over 9 years (2000-09) for their respective zip codes (the top 10% of zip codes for hospitalizations in Denver). Denver Public School data show that rates for fighting in Montbello and NEPH schools (2008-09 school year) were 81.46 and 125.03 per 1,000 students, respectively. Rates for offenses, including violent offenses, which resulted in out of school suspensions or expulsion (2009-10 school year) per 1,000 students were 122.65 in Montbello and 100.38 for NEPH. To study the effects of a MF-EB approach to prevent youth violence in a high- risk community, the project will implement an EB community-level coalition with a public health approach. School and community surveys will identify risk and protective factors. A community action plan with an MF will be developed to address priorities. Health care professionals will be trained to use a Violence Injury Protection and Risk Screen to identify youth at risk for future violence to integrate the health care setting into the model. Finally, the ACE will train medical providers and public health and behavioral science researchers in violence prevention research through a series of seminars and direct involvement in violence prevention research.

Public health relevance
Project Narrative The proposed project will work with a neighborhood organization to implement youth violence prevention activities in a high-risk neighborhood of Denver, Colorado. The goal of the prevention activities is to reduce the level of neighborhood youth violence and the success of the activities to reduce youth violence will be carefully studied. In addition, the project will integrate primary health care settings into youth violence prevention activities by providing tools for determining risk for violence and identification of intervention options, and will train doctors, medical personnel, and research scientists in violence prevention activities and research. __SpecificAimsTextDelimiter__ 2. Specific Aims The aims of this research are to: 1) Reduce absolute and relative (compared to a comparison site) levels of youth violence among ages 10 to 24 in a high-risk community; 2) Demonstrate the impact of a coordinated community wide effort to reduce violence through the evaluation of the effectiveness of a multi-faceted, evidence-based primary prevention/intervention approach; and 3) Train youth violence prevention researchers in the fields of behavioral science, public health, and adolescent medicine and train medical practitioners to recognize and treat youth violence. The general hypotheses for this research include: (1) By providing a community (a) with empirical evidence about the nature and level of risk and protective factors occurring in the community, and (b) information about evidence based practices and programs that have been shown to reduce violent behavior and that target various community, school, family, and individual factors, then (c) the community can make a wise decision about which practices and programs are most likely to be more efficacious in reducing youth violence; and (2) that careful implementation of the selected programs will substantially reduce levels of community violence. We intend to test these stated hypotheses, by creating a novel combination of violence and violence risk assessment, interventions, and evaluation design, and in collaboration with a local hospital, address the problem of high levels of violence in the community. In addition we will test the hypothesis that the evidence based programs implemented will have a statistically significant effect on their targeted risk and protective factors and targeted outcomes. The outcomes expected are that the selected high-risk intervention site will achieve a substantively and statistically significant reduction in the overall levels of violence compared to those in a comparison site. By substantive reductions, we propose to match or better the reductions in the rates of violent behavior called for in the objectives of the Healthy People 2010 framework for the Injury and Violence Leading Health Indicator. Specifically we intend to test the following objectives for each goal of the intervention: Aim 1: Reduce absolute and relative (compared to a comparison site) levels of youth violence among ages 10 to 24 in a high-risk community and test the statistical and substantive significance of these reductions. Objectives: 1. Reduce self-reported violence in the intervention community; 2. Reduce reported community gang related violence in the intervention community; 3. Reduce rates of arrest for serious violent crime in the intervention community. 4. Achieve greater reductions in self reported, official, and gang related violence in the intervention community as compared to a comparison community. Aim 2: Demonstrate the impact of a coordinated community wide effort to reduce violence through the evaluation of the effectiveness of a multi-faceted, evidence-based primary prevention/intervention approach; Objectives: 1. Year One, complete 4 of the 5 phases of the Communities That Care system and baseline data Collection: (a) Getting Started; (b) Establishing a community coalition; (c) Developing a Community Profile through school and community surveys, agency records and other archival data; and (d) Creating a Community Action Plan. Also by the end of Year One, complete baseline data collection efforts in the comparison community; 2. Years 2 to 4, implement evidence-based programs and strategies chosen by the intervention site community board; 3. Conduct a process evaluation to assess adherence to the Communities That Care intervention system and monitor intervention program fidelity. 4. Evaluate specific evidence based programs implemented to determine their impact on their targeted risk/protective factors and outcomes. Aim 3. Provide training activities for junior youth violence prevention researchers and medical practitioners in the fields of behavioral science, public health, and adolescent medicine. Objectives: 1. Provide cross-disciplinary research training for graduate students and health care professionals; 2. Provide hands-on experience for advanced graduate students and medical practitioners; 3. Expose public health trainees to clinical programs focused on youth violence prevention; 4. Provide a framework and research site for behavioral public health trainees to conduct primary violence research